Data Science Core

Data Science Core Summary
The Data Science Core for Biomedical Research (DSC), based at the University of Louisville Health
Science Campus and the University of Kentucky, consists of several components designed to strengthen the
research capacity of researchers and build upon data science training for faculty, staff, and students at primary
undergraduate institutions (PUIs) within the larger KY INBRE network. Components of the DSC include the
Bioinformatics Training and Education Center (BTEC), Genomics Training and Education Center (GTEC), Image
Training and Education Center (ITEC), and the Predictive Analytics and Data Science (PADS) Hub that work
together with the University of Louisville Bioinformatics Core (BC) and Sequencing Technology Center (STC).
In order to fulfill the mission of the DSC within the KY INBRE network, seven specific aims have been established
that will (1) support the generation and analysis of genomic datasets from Illumina, Pacific Biosciences, and
Oxford Nanopore sequencing technologies; (2) provide hands-on training in imaging, genomics, and
bioinformatic technologies; (3) provide expertise on experimental design and usage of appropriate statistical
methodologies; (4) aid in the integration of publicly available data from resources such as dbGAP, GTEx,
Genome Data Commons, The Cancer Genome Atlas, and ENCODE; (5) provide workshops for undergraduates,
graduates, staff, and faculty; (6) support data science initiatives at PUIs; and (7) provide PUI access to scientific
cores in IDeA states across the southeast region.